Molecular Basis of Yellow Fever Virus Viscerotropism

DESCRIPTION (provided by applicant): Yellow Fever (YF) virus causes hemorrhagic fever. It is a category A select agent and re-emerging disease in regions of South America and Africa. Currently, the molecular basis of viscerotropism of YF virus is poorly understood; however, the recent development of a small animal model for viscemtropic YF virus infection enables elucidation of the molecular determinants of YF virus viscerotropism. Detailed molecular characterization of the viscerotropic Asibi/hamster p7 virus will identify regions of the genome that are important in determining the viscerotropic phenotype. This will involve the following specific aims. Aim 1: Identification of the nucleotide and deduced amino acid changes present in hamster viscerotropic viruses by nucleotide sequence analysis. Comparison of the genomic sequence of the viscerotropic Asibi/hamster p7 virus with that of the parental Asibi/hamster p0 virus and other intermediate passage viruses will identify changes most likely to be important in the viscerotropic phenotype. Aim 2:Development of an infectious clone of YF virus to study the effects of mutant genes and gene regions on hamster viscerotropism. These studies will allow the identification of the region(s) of the YF virus genome that are involved in hamster viscerotropism. Aim 3: Identification of specific amino acid mutations involved in the hamster viscerotropic phenotype, and investigation of the molecular mechanism of hamster viscerotropism with respect to virus receptor interaction, liver pathology, and viremia. Detailed characterization of mutant viruses constructed in Aim 2 will identify potential mechanisms of viscerotropism in the hamster model.